Mechanisms of Seizure Resistance in a Mouse Genetic Model with Altered Metabolism

PROJECT SUMMARY / ABSTRACT
Drug-resistant epilepsy is seriously debilitating and very common, affecting about one-third of the 1-2% of people
who experience epilepsy during their lifetime. One of the most effective treatments for drug-resistant epilepsy is
dietary therapy, in the form of a very-low-carbohydrate, ketogenic diet. Despite its effectiveness, this diet is not
very widely used because of the stringency of the diet and the high commitment required of clinicians and other
caregivers. It would be very valuable to understand the mechanism by which altered metabolism produces
resistance to epileptic seizures, to “reverse-engineer” it, and to discover alternative pharmacologic ways of
tapping into this potent and apparently unique anti-seizure mechanism.
We have identified a mouse model that recapitulates the seizure resistance seen in ketogenic diet, but that
involves a mutation in a single gene, Bad. The seizure resistance in this genetic model is due to alteration in
brain cell metabolism, with less glucose utilization and better utilization of alternative fuels such as ketone bodies,
similar to the metabolic changes on a ketogenic diet. We have also discovered a downstream mechanism that
is altered both by Bad alteration and by ketogenic diet: a metabolically sensitive class of ion channels, the ATP-
sensitive potassium channels (KATP channels), become more activated in response to metabolic changes. These
channels are critical for seizure resistance of the Bad-altered mice, and we have also found that they are
responsible for anti-seizure effects of BAD knockout in a brain slice model of seizure.
Recent findings reveal that BAD knockout produces specific changes in core carbon metabolism – specifically
in the pentose phosphate pathway (PPP) – and that direct manipulation of the PPP can recapitulate the cellular
changes in KATP channel activity that underlie the metabolic seizure resistance in BAD knockout. We propose
to test two complementary hypotheses of how altered PPP activity can signal to KATP channels, and distinguishing
these hypotheses is important because they make opposite predictions for how antioxidants, alternative neuronal
fuels, and oxidative signaling may alter the antiseizure effects both in BAD knockout and in dietary treatment.
One hypothesis focuses on the reduced ability in BAD knockout for the neuronal PPP to produce NADPH, which
is central to cellular antioxidant function; this could make native reactive oxygen signaling more effective. The
second hypothesis is that it is not the reduced ability to produce the NADPH byproduct, but rather the reduced
substrate flux through the PPP that alters downstream energy metabolism. We will also expand our in vivo
studies, testing the ability of BAD and PPP manipulation to affect seizures in a chronic mouse model of epilepsy,
Together these studies will reveal the mechanistic basis of metabolic seizure resistance, and will point toward
new therapeutic avenues for drug-resistant epilepsy.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Drug-resistant epilepsy is a debilitating disease that affects millions of people. One of the most effective treatments is dietary therapy that changes brain metabolism, but the mechanism by which this difficult diet prevents seizures remains poorly understood. This study uses gene alteration in a mouse to produce a similar metabolism-based seizure resistance, and to define the molecular and cellular mechanism for this seizure resistance and discover pharmacological tools that mimic it, with the ultimate goal of finding new therapeutic approaches that exploit this anticonvulsant mechanism.